Development, characterization and application of CRISPR/Cas9 gene drive technologies and related active genetic elements to benefit research and society at large

PROJECT SUMMARY On the morning of December 18th 2014, I arrived in the laboratory early to check on my experiment ? what ended up being the ﬁrst proof that the Mutagenic Chain Reaction (MCR) functioned as a highly efﬁcient CRISPR/Cas-based gene-drive system in fruit ﬂies [1]. I later built a similar, albeit more complex, MCR construct in mosquitoes, that was tested in collaboration with the James group (UCI) [2]. As was the case for the fruit ﬂy element, the mosquito MCR propagates with exceptional efﬁciency (99.5%) via the germline. During this process, my advisor Ethan Bier and I expanded the concept of `active genetics' [4] to a family of genetic elements that actively copy themselves onto the companion chromosome (as in the MCR). These elements bypass the constraints of Mendelian inheritance, thereby potentially overcoming current limitations in laboratory experiments. Gene drive systems can be used to combat vector-borne diseases thereby beneﬁting global public health (e.g., malaria eradication), as well as to restore native ecosystems (e.g., suppress invasive species populations). Although I am interested in future applications in diverse ﬁelds, during the award period I will focus on deepening the knowledge on the mechanism of action of active genetic elements in the fruit ﬂy. Here I propose to build and characterize in Drosophila melanogaster three categories of active genetic elements: (1) Full MCR-gene drives, (2) Split, “transcomplementing-MCR”, an alternative that could offer advantages when performing population modiﬁcation in the wild, (3) Reversal constructs to stop, limit or reverse the spread of a Cas9-based gene drive in the wild. 1) I will examine the basis for the extraordinary efﬁciency of our existing gene drive technology and reﬁne its functionality for future ﬁeld applications. Several gene drives, based on MCR technology, will be developed in the fruit ﬂy. Different regulatory regions will be identiﬁed to drive the expression of the Cas9 nuclease in the most effective time during development while assuring its restriction to germline cells. 2) I will build and test trans-complementing-MCRs in which the two primary MCR components (Cas9 and gRNAs) are split in two separate transgenic constructs. Each component individually would not generate inheritance bias; only when combined will these elements reconstitute a gene drive arrangement. This technology could be used in population suppression schemes where a full gene drive, purposely affecting ﬁtness, would otherwise render problematic the ampliﬁcation of the laboratory population to the levels necessary for ﬁeld release. 3) I will develop reversal constructs that can counteract the spread of a Cas9-based gene drive construct in a population. I will test two different types of such constructs: the ﬁrst one acts by cutting out and replacing the gene drive at the same locus at which it is inserted; the second type is located in a different location in the genome, but carries guide-RNAs able to exploit the Cas9 protein to disrupt the Cas9 gene itself.

Public health relevance
PROJECT NARRATIVE Gene drive mechanisms increase the chance that a genetic characteristic is inherited by its progeny. We have developed a highly efficient gene drive system in the fruit fly and adapted it to the disease-vector mosquito Anopheles stephensi, where it faithfully transmits a malaria- resistance gene to nearly all progeny. The developed system has tremendous potential in benefit research, global eradication of vector-borne diseases and restoration ecosystems from invasive species.